Use of Tiered Genetic Sequencing and Specialty Referral for Identifying and Managing Rare Genetic Causes of Chronic Suppurative Respiratory Disease

PROJECT SUMMARY/ABSTRACT
Chronic suppurative respiratory disease is characterized by persistent and recurrent otitis media, sinusitis,
bronchitis as well as bronchiectasis. Genetic etiologies include inborn errors of immunity (IEI) with defective
cellular and antibody-mediated responses and disorders of impaired mucociliary clearance like primary ciliary
clearance (PCD). Early and accurate diagnosis of these genetic etiologies can lead to more effective prevention
of recurring infections, functional decline, and structural respiratory tract damage. Prior studies conducted by the
NIH-funded Genetic Disorders of Mucociliary Clearance Consortium (GDMCC) focused on characterizing
patients presenting with suspected PCD. These led to better understanding of the clinical phenotype and
contributed to the discovery and characterization of over 50 genes causing this disease. Those studies also
showed that some patients presenting with signs and symptoms of PCD actually had milder or later onset
manifestations of IEI identified genetically. This project seeks to complement the extensive PCD clinical, genetic
and management experience of the GDMCC with the corresponding IEI expertise of the NIAID Sequencing and
Primary Immune Deficiency Programs to test our central hypothesis that tiered clinical and genetic evaluation of
patients with suppurative respiratory disease will identify people whose confirmed genetic diagnosis of PCD or
IEI requires whole genome sequencing and expertise in variant significance resolution. Utilizing patients
identified from a multicenter GDMCC suppurative respiratory disease protocol, we propose the following aims:
Specific Aim 1: Assess the potential of Whole genome sequencing (WGS) for diagnosis of IEI or PCD in
patients who have undergone a systematic evaluation for suppurative respiratory tract disease and have
negative commercial IEI and PCD gene testing panels. Expertise in variant curation and significance
resolution for gene variants not currently categorized as pathogenic or likely pathogenic will be utilized to confirm
the genetic diagnoses. Specific Aim 2: Referral of GDMCC patients to the NIH Clinical Center for NIAID
protocol directed clinical, laboratory, or genetic diagnostic evaluation will facilitate confirmation of
genetic IEI diagnosis. Patients will have the opportunity to participate in NIAID protocols designed to more
precisely define immune disorders at the NIH Clinical Center. Specific Aim 3: Referral of GDMCC IEI patients
to the NIH Clinical Center for NIAID protocol directed biologic, gene correctional or transplant treatment
will enhance therapeutic options. Patients diagnosed with a genetic IEI will have access to potential lifesaving
therapeutic advances. The collaborative efforts between the multi-site GDMCC based at the University of North
Carolina at Chapel Hill and the NIAID Centralized Sequencing Program, and Primary Immune Deficiency
Program based at the NIH Clinical Center will lead to improved genetic diagnostic capabilities and optimization
of management strategies for patients presenting with chronic suppurative respiratory disease.

Public health relevance
PROJECT NARRATIVE Chronic suppurative respiratory tract disease is typically characterized by persistent and recurrent ear, sinus and bronchial infections and eventually bronchiectasis. Genetic causes include primary ciliary dyskinesia associated with abnormal airway clearance and inborn errors of immunity which can have very similar clinical presentations. The purpose of this application is to evaluate a stepwise process for identifying, diagnosing and managing these genetic diseases which can lead to increased possibilities for precision treatments and improved clinical outcomes.